CT SCAN ANALYSIS OF FAMILIAL MONDINI INNER EAR DYSPLASIA

The purpose of this study is to determine the mode of inheritance of nonsyndromal Mondini inner ear dysplasia, an inner ear malformation causing deafness, vestibular dysfunction, and recurrent meningitis.